Bladders and biomes: Environmental compounds as modifiers of microbiomes, metabolomes, and urothelium

PROJECT SUMMARY / ABSTRACT
Bladder cancer (BC) is the tenth most diagnosed cancer in the world, and is strongly linked to environmental
chemical exposures including benzo[a]pyrene (BaP). BaP is a polycyclic aromatic hydrocarbon (PAH) and
widespread pollutant found in automobile exhaust, tobacco smoke, and charred food, but the mechanisms
underlying the links between BaP and BC remain unclear. Additionally, not all individuals exposed to BaP
develop BC, indicating that there are additional undefined or individualized risk factors associated with BC.
While human cells can metabolize BaP, host-associated microbes can too. Moreover, host-associated
microbiomes, like host genomes, are individualized, which could drive differences in host responses to BaP
exposure. However, the role of microbes in BC, and specifically, how the gut and urine microbiome modulate
exposure to BaP, is largely unexplored. There is a critical need to evaluate chemical-microbe-host interactions
in relation to high-risk chemicals – like BaP – on bladder health. The objective of this application is to define
microbial metabolism of BaP in vitro and in vivo and asses the effects of this metabolism on the urothelium.
BaP along with its metabolites are excreted in urine, have been linked to BC, and can be metabolized by
microbes. However, it is unknown if microbial metabolism of BaP is occurring in vivo and how the microbiome
may influence this metabolism. Our overarching hypothesis is that microbial metabolism of BaP is playing a
role in bladder carcinogenesis. Specifically, we predict that urine and stool microbes can either “toxify” or
“detoxify” BaP, with “toxifying” metabolism defined here as that which yields secondary metabolites more
damaging or carcinogenic to host cells. In our first aim, we will characterize metabolism of BaP in vitro by
urothelial cells and by gut or urinary tract-associated microbes. Host cells and bacteria will be grown in the
presence or absence of BaP, separately and together, and we will apply targeted metabolomics (GC-MS) to
quantify BaP metabolism. In the second aim, we will characterize metabolism of BaP in vivo through the gut
and urine microbiome and metabolome of mouse models with differing microbial community profiles. In aim
three, we will evaluate urothelial response (toxicity and inflammation) to BaP exposure in vitro and in vivo using
samples from the first two aims. The proposed research is innovative because it represents a substantive
departure from the status quo by defining chemical-microbe interactions and their direct impact on the bladder
epithelium. This approach will create novel opportunities for bladder health and BC management through
microbial community manipulation and engineering. Upon completion of the proposed aims, we will have
identified which microbes can metabolize BaP, how they do so, if this metabolism is occurring in vivo, how
differing microbial communities influence this metabolism, and how this affects urothelial response. This
research is significant because it will establish a novel chemical-microbe-host framework for evaluating
chemical safety, bladder health, and BC development.

Public health relevance
PROJECT NARRATIVE Bladder cancer is strongly linked to environmental chemical exposures including polycyclic aromatic hydrocarbons (PAHs), but the mechanisms underlying these links remain unclear, and not all exposed individuals develop bladder cancer. PAHs like benzo[a]pyrene (BaP) are found in automobile exhaust and tobacco smoke, and differential metabolism of these chemicals by host-associated microbes could be a contributing factor to bladder cancer pathogenesis; therefore, the aim of this proposal is to define gut and urine microbial metabolism of BaP and determine how this metabolism affects bladder cells. This work impacts public health by establishing a novel chemical-microbe-host framework for evaluating bladder health within the broader context of bladder cancer development.